Biobehavioral Trajectories of Social Anxiety from Early to Middle Adolescence

This document has not been changed from the original submission.

Public health relevance
This document has not been changed from the original submission.